Investigating the roles of oncogenic extrachromosomal circular DNAs in cancer

ABSTRACT
Increased oncogene expression mediated by focal amplifications is a common mechanism for oncogene
activation in human cancers. Two major mechanisms leading to oncogene amplification have been described:
chromosomal amplification and non-chromosomal amplification. The latter mechanism is characterized by the
presence of multiple copies of circular DNAs that are thought to originate following the fragmentation and
subsequent circularization of pieces of chromosomes. These “extrachromosomal circular DNAs” (ecDNAs) have
long been known as “double minutes” for their appearance in metaphase spreads and by the lack of centromeric
sequences.
In the past few years renewed interest in this class of cancer-associated chromosomal rearrangements has been
fueled by technological advances and by the realization that, due to their random segregation at mitosis, ecDNAs
can accelerate tumor evolution, mediate drug resistance, and generally promote a more aggressive phenotype.
Despite substantial progress, however, several key questions regarding the biology of ecDNAs, their dynamics
during the early stages of tumor formation, and their contribution to tumor initiation and progression, remain
unanswered. This is in part due to the lack of effective means to engineer and track ecDNAs in normal cells and
in model organisms.
Our group has extensive expertise in the generation and characterization of germline and somatic mouse models
of human cancers, and we have pioneered the use of somatic genome editing to engineer chromosomal
rearrangements in mice. In this grant application, supported by strong preliminary data, we describe a novel
general strategy to model ecDNAs in cells and in mice.
We have already generated three new genetically engineered mouse strains in which the formation of ecDNAs
containing the oncogenes most commonly amplified in human cancers can be induced in a temporally and
spatially controlled manner. Using a similar strategy, we have also generated cell lines in which formation of
specific ecDNAs can be induced and tracked non-invasively using fluorescent reporters and selectable markers.
We propose to use these innovative tools and reagents to address the following key questions:
1) Can oncogenic ecDNAs initiate tumor formation and/or accelerate tumor progression and metastasis in vivo?
2) How do oncogenic ecDNAs respond to changes in intracellular and extracellular environment?
3) Are there mechanisms preventing ecDNA formation and propagation in primary cells?
4) Is the presence of ecDNAs in cancer cells associated with unique therapeutically actionable vulnerabilities?
5) Can ecDNAs be transmitted horizontally between cells?

Public health relevance
PROJECT NARRATIVE We propose to investigate an important and common class of cancer associated genetic lesions in which cancer driver genes (oncogenes) are amplified as part of circular extra-chromosomal DNA molecules (ecDNAs). There is substantial evidence that ecDNAs are involved in cancer pathogenesis, but progress in the field has been limited by the lack of effective means to induce the formation of specific ecDNAs model organisms. To address this important limitation, we have developed a novel strategy that we will use to study the biology of ecDNAs in normal and cancer cells, and to study their ability to promote cancer formation in genetically engineered mice.